Molecular, Genetic and Cellular Targets of Cancer Training Program

The Molecular, Genetic, and Cellular Targets of Cancer Training Program (TCTP) at the University of Minnesota (UMN) provides comprehensive laboratory-based training for predoctoral and postdoctoral trainees, preparing them to become research leaders in the therapeutic targeting of the molecular, genetic, and cellular mechanisms of cancer. With 35 faculty preceptors and 3 advisors, the TCTP emphasizes cutting-edge cancer research areas, including molecular targeted therapies, cancer genetics/epigenetics/genomics, cancer immunology, and tumor microenvironment studies, aligning with the UMN Masonic Cancer Center (MCC) mission to advance cancer prevention and treatment strategies. For the next funding period, several new initiatives are planned. These include a leadership transition, with Dr. Scott Dehm succeeding Dr. Carol Lange as Program Director, as well as the addition of administrative support from the MCC Education and Training Office. This will be coupled with enhanced trainee orientation and a new flexible training framework for postdoctoral trainees, allowing customization of coursework based on individual backgrounds and research needs. The program will also introduce modular training electives in advanced topics such as bioinformatics, genomics, and cancer immunology, reflecting emerging priorities in cancer research. Additional innovations include near-peer mentoring, individualized fellowship writing workshops, expanded mentor training for faculty, and a new monthly networking event designed to foster informal interactions among trainees, faculty, and TCTP alumni. The TCTP supports trainees’ participation in national conferences, MCC symposia, and professional development workshops. Career development initiatives, such as leadership training, team management, and professional seminar coaching, ensure that trainees are well-prepared for competitive roles in academia, industry, and other scientific venues. With the continued support of the MCC and the UMN Medical School, along with these new initiatives, TCTP remains a premier training program for laboratory-based cancer researchers and will continue contributing to the discovery of innovative cancer therapies.

Public health relevance
The goal of the Molecular, Genetic, and Cellular Targets of Cancer Training Program (TCTP) at the University of Minnesota is to provide interdisciplinary laboratory-based training for predoctoral and postdoctoral trainees focused on cancer research. With support from the Masonic Cancer Center (MCC), the TCTP equips trainees to investigate the molecular, genetic, and cellular mechanisms driving cancer and develop targeted therapeutic strategies. By integrating mentoring, collaboration, career development, research, and quantitative biology training, the TCTP prepares the next generation of independent cancer researchers.